SUDDEN INFANT DEATH SYNDROME (SIDS) RISK REDUCTION

The purpose of this project phase is to continue supporting and conducting safe infant sleep outreach with and within AI/AN communities, while also increasing support for these efforts from Tribal leadership, building partnerships with maternal and child health providers, and creating an infrastructure to facilitate dissemination of SIDS/SUID risk-reduction and other infant mortality reduction information.